Multispectral Imaging of Neurons and Astrocytes: Revealing Spatiotemporal Organelle Phenotypes in Health and Neurodegeneration

PROJECT SUMMARY/ABSTRACT
Frontotemporal dementia (FTD) and amyotrophic lateral sclerosis (ALS) are now thought to
represent a spectrum of rapidly progressing neurodegenerative diseases. There are currently no cures
or effective treatments for them. Though separate entities, these diseases share common genetic and
pathological hallmarks and can have overlapping clinical presentations resulting in FTD-ALS. The
underlying genetics linked to FTD, ALS, and FTD-ALS span a broad range of functions, making it difficult
to interpret their contribution to disease pathophysiology. Moreover, most cases (70% FTD, 95% ALS)
are sporadic with unknown etiology. Therefore, new techniques are needed to evaluate cellular
pathomechanisms in the FTD-ALS spectrum of diseases. Because many causative genes are integral to
organelle functions or contacts, we propose to use Multispectral Imaging (MSI) as a novel approach to
accomplish this goal. MSI is a cutting-edge confocal microscopy technique used to simultaneously
visualize up to seven fluorescent labels in living cells. In the proposed work, we will label major
membrane-bound organelles (endoplasmic reticulum, peroxisomes, Golgi apparatus, mitochondria,
lysosomes, lipid droplets) to quantify organelle morphology, interactions, and dynamics that are integral
to cell function and/or perturbed in disease. The resulting organelle metrics will be combined to produce
an organelle signature for neurons and astrocytes, cell types relevant to FTD-ALS. To our knowledge,
this is the first study to utilize MSI to assess cellular mechanisms of the brain. Therefore, Aim 1 will
establish organelle signatures for healthy neurons and astrocytes, examine how the signatures change
upon pharmacological perturbations, and create a platform to automate the MSI analysis process. We
hypothesize that neurons and astrocytes will have disparate organelle signatures related to their differing
physiology. Aim 2 will evaluate FTD-ALS phenotypes induced by a familial mutation in the TARDBP
gene. TARDBP encodes the TDP-43 protein, which has been identified to aggregate in the majority of
FTD and ALS cases (45% and 97%, respectively). We hypothesize that this neurodegenerative
perturbation will result in aberrant organelle morphology and dynamics in both neurons and astrocytes.
Our preliminary findings demonstrate the feasibility of our approach and a likelihood of success, as we
have optimized MSI labels in both cell types and began to examine pharmacological and genetic
perturbations that result in altered organelle morphology and interactions. To substantiate our findings,
we will confirm and expand on the MSI data in human induce pluripotent stem cell-derived neurons and
astrocytes and validate significant phenotypes in FTD-ALS brain tissue. Our study will establish MSI as
an innovative approach to evaluate neurodegeneration and could reveal cellular phenotypes integral to
FTD-ALS onset or progression that traditional techniques have thus far missed.

Public health relevance
PROJECT NARRATIVE Discerning neurodegenerative disease pathomechanisms have been challenging due to disease polygenicity, largely unknown etiology, and the involvement of multiple cell types. This proposal implements multispectral imaging (MSI) as a feasible, innovative, and unbiased approach to investigating the cellular physiology of neurodegenerative diseases in disease-relevant cell types. Applying this systems-level approach to neurons and astrocytes will enhance our understanding of TDP-43 proteinopathies, namely frontotemporal dementia (FTD) and amyotrophic lateral sclerosis (ALS).